Chylomicron-responsive Tregs in EED

Abstract.
A quarter of the world’s children experience chronic malnutrition coupled with a lack of access to clean drinking
water. This combination results in Environmental Enteric Dysfunction (EED), a disease where intestinal
malabsorption exacerbates malnutrition, leading to increased cognitive deficiencies, stunted growth and
mortality. The intestine of EED patients is characterized by inflammation and flattened villi in the small intestine
that negatively affect absorptive capacity. Our groups have recently identified a pool of protective Tregs in the
small intestine that respond specifically to dietary lipid absorption, to the presence or absence of chylomicrons
secreted in response to dietary lipids, and to EED. We hypothesize that lipid absorption and chylomicron
secretion is reduced in the EED intestine, that EED-chylomicrons deliver less dietary triglyceride to mesenteric
LN Tregs, and that replenishing calories by bypassing the chylomicron pathway (with a medium-chain-
triglycerides) will restore calories without blocking the effect EED-chylomicrons that will travel by the lymph to
stimulate protective intestinal Tregs.

Public health relevance
Narrative. A major challenge to treating Environmental Enteric Dysfunction (EED) is to replenish calories while not losing protective anti-inflammatory Tregs. Our labs have discovered a critical role for Roryt+ Tregs, dietary lipid absorption, and Treg metabolism in protecting the gut, in a novel mouse model of EED. Our proposed studies will define how chylomicrons from EED mice act in Tregs, and whether this mechanism can be targeted through therapeutic dietary intervention.